Organometallic Sensors for Cellular Small Molecule Detection

7. Project Summary/Abstract
The adaptation of abiotic transition metal catalysts for applications in biological systems has undergone
remarkable growth in recent years with examples ranging from artificial metalloenzymes to molecular
probes for detection of challenging analytes such as carbon monoxide. The PI has a standing interest in
discovery, development, and understanding of strategies for detecting challenging biologically relevant
molecules via the unique reactivity of transition metals. Most recently, the Michel group reported BODIPY
Ethylene Probes (BEPs) as the first profluorescent Activity Based Sensors (ABS) for the detection of
ethylene in biological systems. These ABS adapted well-known ruthenium olefin metathesis catalyst, which
are known to readily react with ethylene.
While ethylene has long been known as an important plant hormone it has also been demonstrated to
be produced in mammals as a result of oxidative stress that is hallmark to numerous diseases. In particular
ethylene arises from the radical fragmentation of lipid peroxides and/or intermediates in their formation.
The formation of lipid peroxides is a result of reactive oxygen species, which are implicated as playing
stress or signaling roles in numerous diseases including cancer, cardiovascular disease, and
neurodegenerative diseases amongst others. While there are some sophisticated spectroscopic methods
for sensitively measuring the biomarker ethylene in exhaled breath, these approaches are necessarily
limited in spatial resolution and complexity of sample. Since reporting our initial ABS approach, our group
has conducted systematic ligand modulation studies to improve probe response time and sensitivity.
Through this work the limit-of-detection was improved nearly two orders of magnitude. Despite these
advancements, important questions remain for broad applications in the detection of endogenous ethylene
related to modifications that further improve sensitivity while retaining robust stability in biological systems.
The next stage of developing this technology will build on mechanistic insight and recent advancements
in catalytic olefin metathesis. This will be accomplished through an interdisciplinary approach of synthesis,
analytical and photophysical characterization, and subcellular localization studies. It is anticipated that the
proposed research will result in highly sensitive ethylene ABS localized to subcellular locations where
ethylene is expected to be found in the highest concentrations. Further we expect to explore novel
strategies for ethylene detection beyond the dosimetric responses generally employed for ethylene and
other small molecule analytes. As has been the case over the past 10-15 years, we envision that there will
be continued growth of transition metal catalysts operating in cellular environments to perform critical
functions that would otherwise not be possible. The research and concepts of the proposed program will
continue to significantly contribute to this field.
1

Public health relevance
8. Project Narrative The proposed project is relevant to public health because it will develop and validate technology to detect ethylene as a unique biomarker of oxidative stress. Ethylene is a product of lipid peroxidation and in-turn a measure of oxidative stress, which is related to numerous diseases. The development of sensitive fluorescent probes could broaden the study of the biological production and role of ethylene, which is in line with the mission of the National Institute of General Medical Sciences (NIGMS). 1